HIDR - Health Informatics in Diabetes Research

PROJECT SUMMARY/ABSTRACT – Health Informatics in Diabetes Research Regional Resource Core
The primary goal of the Health Informatics in Diabetes Research Regional Resource Core (HIDR) is to advance
the development and application of health informatics focused on translating interventions to reach populations at
risk for diabetes disparities. HIDR has provided health informatics support for a wider scientific community of
Washington University Center for Diabetes Translation Research (WU-CDTR) investigators focused on improving
diabetes translation research through the technology and information environment. Poor access to care,
particularly for rural populations, is a barrier to improving diabetes outcomes; informatics strategies (e.g.,
telehealth) can help overcome these barriers.
The HIDR Core capitalizes on collaborations with the University of Missouri’s statewide network of health
care sites and extension centers, as well as the Missouri Telehealth Network, an innovative program that reaches
socioeconomically disadvantaged rural communities across the state in partnership with health care
organizations and key stakeholders. HIDR services have expanded in response to the use of health information
technologies (e.g., eHealth, mHealth, and telehealth) and the requests for services addressing the root causes of
diabetes inequities. HIDR is valued for its expertise in responding to rapid changes in healthcare arising from
increased use of health information technology, telehealth, and complex big data sets.
The specific aims of the HIDR services for WU-CDTR investigators are to: (1) expand the application of
evidence-based health information technologies in diabetes translation research; (2) increase the capacity for the
use of telehealth in diabetes research among WU-CDTR investigators; and (3) advance means of managing,
scaling, and analyzing information from large, heterogeneous data sets to accelerate the progress of diabetes
translation research.
HIDR provides Center investigators the expertise and resources needed to ensure excellence in the
conduct of health informatics diabetes translation research, and the opportunity to achieve diabetes health equity
in rural and disadvantaged populations. HIDR support of diabetes translation research is needed to accelerate
new and evolving methodologies and approaches to care that improve health outcomes.